Understanding the miRNA response to opioid withdrawal and their uses as potential biomarkers for neonatal abstinence syndrome

Project Summary/Abstract
Neonatal abstinence syndrome (NAS) is characterized by central nervous system hyperactivity that
occurs when an infant experiences withdrawal from maternal opioid use at birth. Rates of NAS in the United
States have skyrocketed amidst the opioid epidemic. Assessment and clinical management of NAS rely on
subjective symptom scales, which may contribute to the prolonged hospital stays and poor neuro-
developmental outcomes associated with NAS. Enhancing our knowledge about the molecular factors that
regulate the biologic response to opioid withdrawal in developing infants will provide an opportunity to create
objective clinical tests and novel therapies for this significant medical problem. To date, there is no biologic tool
to determine the necessary morphine dose in withdrawing infants, or to predict which infants will experience
neurodevelopmental delays. This is partly due to the fact that prior studies have largely focused on the
molecular response to opioid administration in adults, rather than the response to opioid withdrawal in infants.
Serum levels of certain micro-ribonucleic acids (miRNAs) are impacted by opioid administration in adults (e.g.,
let-7a, miR-146a, miR-192). These short, non-coding nucleic acids also regulate neurogenesis, neuronal
progenitor cell (NPC) maturation, and cell survival by repressing target messenger RNAs in the Argonaute
complex. My sponsor, Dr. Steve Hicks, MD, PhD has pioneered the use of salivary miRNAs as non-invasive
markers for pediatric neurodevelopmental conditions. Most salivary miRNAs are derived from exosomes, which
can arise from the cranial nerves that densely innervate the oropharynx. My preliminary data shows that
several “opioid-responsive” miRNAs are perturbed in the saliva of infants with NAS relative to healthy infants.
Further, I have developed an in vitro system of opioid withdrawal utilizing human NPCs that displays dose-
related perturbations in miR-146a along with disruptions in NPC fate. Based on these findings, the central
hypothesis of my fellowship application is that morphine withdrawal alters miRNA expression in the developing
brain, which impairs neuronal maturation by mRNA translation via Argonaute binding. I also hypothesize that
salivary levels of exosomal miRNAs from infants with NAS will be directly related to both the maximal dose of
morphine required for symptom control, and neurodevelopmental outcomes at six months. I will test these
hypotheses in two specific aims. First, I will perform a longitudinal cohort study of 50 infants with NAS to
determine whether salivary miRNA levels within brain-related exosomes can be measured at admission to
predict the maximum morphine dose required for symptom control, and again at discharge to predict
neurodevelopmental outcomes at six months (Aim 1). Second, I will transfect miRNA mimics in my in vitro NPC
design of opioid withdrawal, and assess the mechanism by which miRNAs impact the response to opioid
withdrawal with immunocytochemistry, single-cell RNA sequencing, and an Argonaute pull-down assay (Aim
2).

Public health relevance
Project Narrative Infants with neonatal abstinence syndrome (NAS) experience prolonged hospital stays and poor neurodevelopmental outcomes, in-part because of the lack of accurate, individualized, biologic assessments available to manage this increasingly common medical condition. The proposed study will define the molecular mechanisms that regulate the response to opioid withdrawal in the developing brain by focusing on three candidate microRNAs (let-7a, miR-146a, miR-192) that have been shown to respond to opioid exposure in animal models and adults, and are impacted in both my preliminary study of infants with NAS, and my human neural progenitor cell (NPC) design of opioid withdrawal. By determining the mechanism through which microRNAs impact NPC differentiation in opioid withdrawal, and determining whether exosomal salivary microRNA levels predict treatment dose and neurodevelopmental outcomes in infants with NAS, this study will enhance our knowledge of NAS-related biology and identify potential biomarkers that could improve medical care for this important medical condition.